Leveraging behavioral economics to equitably implement cascade screening in individuals with familial hypercholesterolemia in partnership with the FH Foundation

The proposed project leverages our longstanding partnership with the Family Heart Foundation (FHF), a nonprofit research and advocacy organization, to refine and test two promising approaches to implement cascade screening in individuals with familial hypercholesterolemia (FH). Despite evidence-based guidelines for FH diagnosis and treatment, over 1 million Americans with this inherited condition remain undiagnosed. Cascade screening is an evidence-based practice of contacting and screening first-degree biological relatives of FH probands, improves timely FH diagnosis, and reduces morbidity cost-effectively. Cascade screening programs have been successful in other countries where health systems play a key role in notifying relatives, but major implementation challenges limit uptake in the U.S. Pilot projects have identified hurdles including regulatory constraints limiting health system outreach and difficulty contacting family members outside a given health system. In the U.S., cascade screening must involve the proband given regulatory constraints. Applying advances in behavioral economics has great potential to improve implementation of cascade screening via proband-mediated strategies. Led by MPIs with expertise in implementation science (Beidas), behavioral economics (Volpp), and FH (Rader), we have co-designed, and will pilot and test two patient-facing implementation strategies to increase reach of cascade screening with 300 probands from Penn Medicine. Our randomized controlled trial will test (a) a health system-mediated strategy using automated text messages, (b) a Family Heart Foundation-mediated strategy using a navigator, and (c) the “usual care” approach to cascade screening. Both active strategies will be informed by behavioral economics. In the R61 phase, we co-designed health system- and FHF-mediated implementation strategies using behavioral economics in partnership with the FHF and key stakeholders (Aim 1) and are piloting our strategies with 20 FH probands to ascertain feasibility, acceptability, and appropriateness (Aim 2). In the R33 phase, we will conduct a 3-arm hybrid Type 3 effectiveness-implementation RCT, and compare the effect of health system-mediated, FHF-mediated, and usual care approaches on reach (proportion of probands who have at least one family member who completes screening), number of family members screened, number of family members diagnosed with FH, and proband LDL-C levels (Aim 1). We will use mixed methods to identify implementation strategy mechanisms (Aim 2). By testing sustainable and scalable implementation approaches, our study results will be poised to guide future wide-scale implementation of cascade screening for FH and other genetic conditions within and outside large health systems while also answering important questions related to implementation for all populations. Successful strategies can be taken to scale nationally to save lives, in keeping with NHLBI Strategic Objective 6.

Public health relevance
Revised Public Health Relevance Section   Access Grant Folder for the selected project and click on “Additions for GM” tab. (This functionality can be accessed by “GM_EADDITION_DOC_UPLOAD_ROLE” or “GRANT_SPECIALIST” role in the IMPAC II application account.)   On “Addition to GM” section click on the “Add Document” button.     Clicking on the Add Document will display File Upload dialog. Select “Award Document: Revised Aims and Abstract” in the “File Group” dropdown menu.   Click on “Add file” and select previously prepared upload file. Label and Comments are option on the File Upload. Click on the “Submit” button to upload the file in to the database. System will validate the file and will display a SUCCESS message, notifying the File Groupe as “RAA” and File name.     Note: During off-peak hours, the uploaded file is processed, and records are inserted and updated in IMPACII. Please allow one business day to view uploaded text in the system. An additional business day is required for the new text to be processed by the RCDC system for new concepts and categorization if the project is associated with the current fiscal year. Note: The graphics cannot be extracted and stored in the system. Example of the word document image   Note 2: All three types of scientific text may be combined in one Word document. Note 1: The specified header is mandatory and is required for the indexing system to correctly identify and save the text.   For Public Health Relevance, use one of these header text statements: Modified Project Summary/Abstract Section Revised Abstract Section For Specific Aims, use one of these header text statements: Modified Specific Aims Section Revised Specific Aims Section For Abstract, use one of these header text statements: Modified Public Health Relevance Section Revised Public Health Relevance Section SF424_RR_Guide_ModifiedScopeTemplate .docx